Modeling Adolescent Health Care Decision-Making

In the US, state- and local-level laws on medical care for minors can directly impact population health. However, the influence of real-world effects (e.g., rural access to providers) on this association is unclear. Currently, healthcare knowledge and access for minors largely differs by state, increasing the risk of negative health outcomes. Traditional efforts that apply mathematical models to examine population-level outcomes do not account for the various state healthcare laws, geospatial effects, local sociodemographics, or individual behaviors. To accurately study the impact that adolescent healthcare laws as well as other real-world effects have on adolescent health, researchers need to apply a comprehensive framework that integrates legal policy with health outcomes. Our proposed model will apply a legal epidemiology framework that integrates legal and health data. It will leverage US census data in an agent-based simulation (Framework for Reconstructing Epidemiological Dynamics; FRED), which was designed to include system-level, sociodemographic, geospatial, and individual effects in its simulation models. Our multidisciplinary team—with expertise in adolescent health, health law, and computational modeling—will merge state- and local-level healthcare laws with nationally representative census data within FRED. We will collaborate with different partners—including parents, school employees, and pediatricians, among others—to understand the impact of these laws on adolescent health, explore potential interventions with different legal restrictions, and inform a simulation model. First, we will develop a comprehensive legal dataset of state- and local-level healthcare laws that impact minors. Second, we will collaborate with partners to understand the influence of these laws and design potential interventions that can improve adolescent health outcomes. Third, we will model the effects of various laws, real-world effects, and potential interventions in FRED to assess the impact of these factors on adolescent health. In summary, this project will result in a comprehensive legal dataset of healthcare laws for minors and an evidence-based predictive model of adolescent health in real-world conditions. The model’s flexibility can inform researchers on the impact of various state- and local-level laws and other real-world effects that can impact population health.

Public health relevance
The goal of this project is to develop a legal dataset of healthcare laws for minors and to model the interplay between these laws and the health of adolescents, leveraging the power of nationally representative data and an agent-based simulation. The project team consists of a group of interdisciplinary researchers, allowing for a rigorous understanding of the impact of healthcare laws and the implications of potential interventions to improve health in adolescents. We will use an agent-based simulation to model the effects of healthcare laws and other real-world effects in different locations to provide researchers with valuable information to inform future policy decisions and intervention development and implementation.